Administrative Core

Project Summary: Administrative Core
This proposed Program Project and its Administrative Core, both led by Dr. Bernardo Rudy, will be based at
the NYU School of Medicine (NYUSoM). With state-of-the-art facilities and access to all essential resources,
NYUSoM is an ideal location to carry out the proposed aims of this PPG, and the members of the PPG benefit
from the larger NYU scientific environment, including the Neuroscience Institute and the Center for Neural
Science. The Administrative Core will provide the important structures and communication plans to promote
the fast sharing of data to promote cohesion and synergy, to promote collaborations among the PIs and
scientific personnel, to ensure that the resources generated by the Molecular and Transgenic Core are shared
and optimally used, to oversee the administrative and financial management of the PPG, and to coordinate the
evaluation of research progress and future directions by an External Advisory Board. Through these activities,
the Administrative Core will help to maximize productivity and accelerate scientific progress. It will also enable
productive and synergistic research to improve our understanding of cortical interneurons, with added insight
into their development, anatomy, circuit integration, and function.